Administrative Core

Administrative Core Abstract
The overarching goals of the Administrative Core are to: 1) Provide effective and efficient administration of
Research Pilot Projects that fosters innovative collaborative cancer disparities research between HU and GU
investigators; 2) Provide efficient administrative support and oversight to facilitate high quality cancer research
experiences and cancer research education programs; and 3) Execute a program planning and evaluation
process that will continuously improve the development of a productive, sustained partnership to continue
collaborative cancer disparities research between the two partner institutions. The Partnership's management
structure is organized into a Leadership Team consisting of the three principal investigators (PI's) and an Internal
Advisory Committee (IAC) made of up equal numbers of senior research faculty from Howard and Georgetown.
The IAC will provide the main advisory and evaluation functions for the scientific, organizational, and strategic
activities of the Partnership. More specifically, the IAC will provide the following three key functions: 1) Peer
review for P20 progress and planning; 2) Scientific review, selection, and evaluation of Pilot Projects and C-REP;
and 3) Promoting sustainability of Partnership gains.